Long-term microglia-targeted endogenous retrovirus-like particle (ERVLP) delivery of Cas12f editor to cure HIV

Summary
Latently infected brain myeloid cells including microglia (MG) and perivascular macrophages can serve as HIV
reservoirs, contributing to NeuroHIV persistence, chronic neuroinflammation and HIV-associated
neurocognitive disorders (HAND). Strategies aimed at eliminating HIV reservoirs are highly promising to cure
HIV, even in the presence of effective anti-retroviral therapy. Extensive studies including FDA-approved phase
I clinical trial have demonstrated the therapeutic potential of CRISPR/Cas genome editing to cure HIV.
However, a major barrier to the clinical application is the lack of effective and specific delivery to the targeted
disease-relevant tissues and/or cells in vivo, particularly in NeuroHIV. The overall objective of this proposal is
to develop AAV-mediated stealth cargo delivery of miniature Cas12f genome editor to the HIV cellular reservoir in
the brain. We will utilize novel PEG10-mediated endogenous retrovirus-like particle (ERVLP) technology that
relies on endogenous PEG10 and syncytin-A for Cargo(Cas12f) mRNA transfer into MG. This approach will
harness the benefits of the most promising AAV gene therapy. Several AAV serotypes such as AAV1, 2, 5, 6
can transduce MG (AAV-M) with >80% efficiency in vitro and in vivo, but cannot cross the blood-brain barrier
(BBB). In contrast, the currently available BBB-penetrating AAV serotypes (AAV-B) such as AAV9, PhP.B,
PhP.eB, F, B10 or B22 have low efficiency in transducing MG both in vitro and in vivo. Therefore, novel AAV
serotypes that effectively cross the BBB and transduce MG (AAV-BM) are urgently needed. We hypothesize
that AAV-B can offer a one-time injectable systemic delivery of stealth cargo (cDNA) into astrocytes and/or
neurons thatin turn serve as relay stationsfor sustained mRNA/sgRNA transfer to MG. This stealth AAV cargo
will also include a designer exosome transfer into cells (EXOtic) device via CD63 linked with MG-specific peptide
(CD63M). We expect that PEG10-mediated ERVLP and CD63M-mediated EXOtic will synergistically boost the
endogenous spreading of HIV eradicator to MG. To accomplish this, we will first use the Cre-LoxP system for
proof of concept that MG-targeted exosome-enveloped ERVLP system (Exo-ERVLP) via AAV-B can efficiently
deliver Cargo(Cre)-mRNA in vivo from transduced astrocytes/neurons to non-transduced MG in LoxP-STOP-
LoxP (LSL)-tdTomato reporter mice (Aim 1). Then, we will assess MG-targeting and genome editing efficiency
of multiplexed Cas12f mRNA/sgRNA sustained delivery in LSL-tdTomato mice and HIV Tg26 transgenic mice
(Aim 2). Finally, we will explore the therapeutic potential of Exo-ERVLP AAV-B-Cas12f systemic injection in
HIV Tg26 transgenic mice (Aim 3). This high-risk high-reward proposal brings together several advancing
technologies and established teams with complementary expertise. The all-in-one multiplexed Cas12f/sgRNA
transgene is delivered via AAV-B, PEG10 cargo and CD63M EXOtic for sustained targeting and HIV
eradication. The expected positive outcomes will offer a novel tool to systemically deliver CRISPR/Cas editor
to MG, and provide new avenues for therapeutics development for multiple MG-related diseases.

Public health relevance
Project Narrative Eradication of HIV in latently infected cells is critical for a cure of HIV and HIV-associated neurocognitive disorders. This proposed research is relevant to public health because the discovery of a novel gene therapy targeting HIV-1 cellular reservoirs is ultimately expected to snip out integrated HIV provirus in the brain. Thus, the strategy to eradicate virus and save host cells in this proposal is relevant to NIH's mission to develop novel therapeutics for the permanent cure of HIV in the presence of substance use disorder.